Understanding the Impact of CACNA1A/unc-2 Mutations on Presynaptic Structure and Function in C. Elegans

Project Summary/Abstract
Mutations in the gene CACNA1A, which encodes Cav2.1, the a1 subunit of P/Q type voltage gated calcium
channels, lead to severely debilitating channelopathies. Patients are classically diagnosed with syndromes such
as episodic ataxia type 2 (EA2) or familial hemiplegic migraine type 1 (FHM1), though some patients also exhibit
intellectual disability (ID) or multiple overlapping symptoms. Prior studies have largely focused on studying
biophysical properties of these channels in heterologous systems or on mouse models of loss-of-function (LOF)
EA2 mutations that have been linked to aberrant cerebellar Purkinje cell pacemaking. FHM1 has been
associated with gain-of-function (GOF) effects leading to overexcitation and cortical spreading depression.
Recent studies have suggested that in vitro characterization often obscures more complex or neuronal
compartment specific effects in vivo. Cav2.1 plays a prominent role at presynaptic terminals to drive vesicular
neurotransmitter release, yet the synaptic effects of many mutations remain understudied. Moreover, the
molecular mechanisms that underlie patient symptoms beyond FHM1 and EA2, such as cognitive dysfunction
are unknown. The overarching purpose of this proposal is to interrogate how two uncharacterized CACNA1A
mutations associated with ID in patients alter synaptic transmission and lead to circuit-wide defects, comparing
their effects on synaptic function to more well-characterized LOF and GOF mutations. The nematode C. elegans
will be used to model patient-derived mutations in vivo, taking advantage of this powerful genetic system. C.
elegans have a single CACNA1A orthologue, unc-2, which displays significant homology to the mammalian
channel. The Kurshan lab has thus far generated five mutant CACNA1A/unc-2 strains, modeling either EA2,
FHM1, or non-syndromic mutations that lead to ID. Aim 1 of this proposal will determine how synaptic function
is altered in these mutant strains by measuring synaptic vesicle release using established and novel behavioral
assays, performing electrophysiological recordings, and imaging channel expression in different cell types. Aim
2 will use molecular cloning techniques, calcium imaging and optogenetics to dissect the neural circuits impacted
by the mutations, as well as a forward genetic screen to identify additional components of the signaling pathways
mediating aberrant circuit output. Completion of this study will lead to a better understanding of the molecular
perturbations caused by ID-associated CACNA1A/unc-2 mutations and work to identify synaptic targets for
therapeutic intervention to treat patients suffering from these neurological disorders. This proposal will greatly
enhance the F31 candidate’s scientific and professional development through strong mentorship and fantastic
support from the Albert Einstein College of Medicine, while also leading towards their goal of becoming an
independent investigator.

Public health relevance
Project Narrative The revolution in genome sequencing methods is increasingly revealing the genetic mutations responsible for neurological dysfunction, yet investigating the underlying molecular mechanisms and ways to alleviate burdensome symptoms is still lagging behind. This project aims to elucidate how missense mutations in neuronal calcium channels impact synaptic transmission using molecular biology, neuroimaging, electrophysiology, and behavioral neuroscience approaches. Understanding the molecular causes leading to disrupted synaptic function will help us identify novel therapeutic targets for patients suffering from these and other neurological diseases.